DEVELOPMENT OF A WEARABLE, NON-INVASIVE, TREATMENT DEVICE FOR METASTATIC TRIPLE-NEGATIVE BREAST CANCER (TNBC)

PROJECT SUMMARY/ABSTRACT
Triple-negative breast cancer (TNBC) is a subtype of breast cancer that is highly invasive, has limited treatment
options, and is prone to recurrence and metastasis. The standard of care for TNBC patients involves neoadjuvant
chemotherapy, followed by surgery and radiotherapy. Even with recent advances in immuno-oncological (I-O)
treatments, the 5-year survival rate for metastatic TNBC is only 12%. Moreover, only some (~20% of TNBC
patients) are eligible for chemo-immunotherapy combination treatment so that a significant patient remaining
population will not benefit from current treatments. Therefore, novel effective therapeutic approaches must be
developed that complement standard treatments for TNBC and enhance immune responses. To meet this urgent
clinical need, we are developing non-pharmacological, wearable, non-invasive, commercially viable medical
devices for treating metastatic TNBC. Using induced electric field (iEF) technology with electromagnetic fields of
intermediate frequency (< 500 kHz) and low intensity (µV/cm–mV/cm), we have already shown in a preclinical
TNBC model in immunocompetent mice that iEF treatment results in a significant decrease in distant
metastases to the lungs, primary tumor burden, infiltration of pro-metastatic tumor associated M2-like
macrophages, and increased infiltration of activated cytotoxic T cells in the primary tumor microenvironment
(TME). This novel iEF therapy elicits potent beneficial and selective biological response by modifying
endogenous electric fields (and potential differences) that exist both at the tissue and cellular levels, by
introducing exogenous voltages and electric fields that hinder tumor growth and metastasis to the lungs. Both
our in vitro and in vivo data support our hypothesis, and the overall goal of this application is to transition our
promising results closer yet to the clinic by combining iEF treatment in mouse models, with standard of care
chemotherapy in advanced TNBC. We will accomplish this goal by (1) determining and establishing the safety
profile of iEF therapy, assessing any adverse effects of iEF therapy in wild-type immunocompetent mice,
identifying any observable effects on standard analytes from blood analysis, and (2) determining the ability of
iEF therapy combined with standard of care chemotherapeutic agents in established mouse models that
recapitulate breast cancer tumor growth, progression, and pulmonary metastasis. We will determine in
vivo the efficacy of standalone IEF therapy in decreasing tumor growth and pulmonary metastasis, and then
assess the efficacy of combining iEF treatment with standard of care chemo-monotherapies (paclitaxel,
capecitabine) in shrinking the primary tumor and preventing pulmonary metastasis. Collectively, this work has
the potential for saving the lives of patients with metastatic TNBC who are not responsive to current standard of
care, and will contribute to lessening the morbidity of current treatments by potentially lowering the required dose
of chemotherapeutic agents.

Public health relevance
PROJECT NARRATIVE Metastasis or spread is the foremost cause of cancer-related deaths. We have developed a wearable, non-pharmacological approach to non-invasively apply induced electric fields (iEFs) and shown in a mouse model, that aggressive breast tumors and their metastasis to the lungs can be reduced significantly. In this work, we are establishing the safety of iEF therapy as a standalone treatment for aggressive breast cancer and assessing efficacy of combining iEF therapy with currently used chemotherapies with the aim of improving effectiveness and patient tolerance of current standard of care.